Targeting oncogenic epigenetic mechanisms in IDHmut/ATRXloss Astrocytoma

ABSTRACT
Astrocytomas (WHO grade II and III) primarily occur in early-middle adult life. Most lower grade
astrocytoma progress to higher grade including GBM (i.e., secondary GBM) despite the best standard-of-care
therapy. Developing more effective therapeutic strategies requires a more complete understanding of the
mechanisms employed by astrocytoma cells to escape anti-tumor immunity. The majority (~80%) of grade II &
grade III astrocytoma carry mutations in isocitrate dehydrogenase (e.g., IDH1R132H), which typically occurs with
p53 mutation and ATRX inactivation (i.e., IDH1R132H/p53mut/ATRXloss, triple-mut for simplicity), indicating that this
triple mutation background has an important role in tumor growth potentially including immune evasion
mechanisms. However, our current understanding of how triple-mut astrocytoma cells modulate the tumor
microenvironment (TME) to suppress anti-tumor immunity is limited and inadequate. The goal of this project is
to elucidate the cellular and molecular mechanisms by which triple-mut astrocytoma cells modulate TME immune
cells and use these discoveries to develop novel strategies to sensitize triple-mut astrocytoma cells to emerging
immunotherapeutics. Our recent published findings and preliminary data show that triple-mut induces multiple
pathways critical to anti-tumor immunity including checkpoint ligands, IFN-γ signaling insensitivity, down-
regulation of MHC-I and -II antigen presentation pathways (MHC APP), and dysregulated cytokine/chemokine
profiles that modulate the astrocytoma immune microenvironment. Furthermore, we found that the components
of the immune-modulating astrocytoma transcriptome are augmented by standard-of-care radiation (IR) and
temozolomide (TMZ). Our findings implicate BET and EHMT as epigenetic determinants of astrocytoma immune-
modulating transcriptome. Building on these interesting findings, we will pursue the following specific aims: (i)
Determine the role of BETs in the immune-suppressive transcriptome in triple-mut astrocytoma cells at baseline
and in response to standard-of-care radiation; (ii) Identify EHMT-dependent methylation events that drive IFN
signaling insensitivity and MHC APP down-regulation in triple-mut astrocytoma cells; (iii) Determine if BET and
EHMT inhibition in combination reprogram astrocytoma microenvironment and sensitize astrocytoma to anti-
CTLA-4 therapy. These experiments will fill critical knowledge gaps in our understanding of BET-dependent and
EHMT-dependent immunomodulatory pathways underlying astrocytoma cell: immune cell immunosuppressive
interactions and their augmentation by IR and establish the potential for combinational strategies to sensitize
triple-mut astrocytoma to emerging immunotherapeutics.

Public health relevance
WHO Grade II and Grade III astrocytomas are common gliomas occurring in early middle adult life. Almost all progress to higher grade including secondary GBM. Grade II/III astrocytomas are distinguished from other gliomas by their typical mutational background consisting of IDHmut/p53mut/ATRXloss and are understudied relative to glioblastoma. Immunotherapy offers great promise in other cancers but has not yet been effective against brain tumors including astrocytoma. This research will use pre-clinical models to identify immunosuppressive transcriptional mechanisms of astrocytoma and amplified by standard-of-care radiation therapy. Positive results will develop a novel combinational immunotherapy strategy for IDHmut/p53mut/ATRXloss Grade II/III astrocytoma.